Ron Receptor Tyrosine Kinase Signaling in Breast Cancer

Breast cancer (BC) is the second leading cause of cancer related deaths among women in the US. While
advances in treatment and early detection have contributed to a decline in death rates, BC is still a major killer
of women both in the US and globally highlighting the need to identify new molecular circuits and treatment
strategies to combat this disease. Work from our funded Merit studies and others has shown that the RON
receptor tyrosine kinase is highly overexpressed in human BCs and is an independent predictor of worse overall
survival, early death and metastatic progression. Interestingly, our recent studies show that RON expression is
independent of molecular subtype suggesting that this protein may serve as a powerful new marker for
metastasis, poor prognosis and recurrence across all BCs. While RON overexpression is a decisive factor in
human BC progression, our knowledge about the mechanisms by which RON promotes the development of
aggressive disease is limited. Previously, our laboratory produced transgenic mice with mammary-specific RON
overexpression. These mice, referred to as MMTV-RON mice, mimic the aggressive disease pattern observed
in human patients with all female mice developing highly metastatic breast tumors. In this clinically relevant
model, we discovered that mammary tumors upregulate the RON ligand, hepatocyte growth factor-like protein
(HGFL). Utilizing MMTV-RON mice deficient in HGFL, we published the requirement of HGFL for oncogenic
RON activation and mammary tumor growth and progression. Utilizing HGFL deficient BC cells, we showed that
reconstitution of HGFL promoted tumor cell autonomous survival, migration and invasion. Further, we showed
that global HGFL loss also reduced breast cancer stem-like cell numbers and altered the tumor
microenvironment (TME) by regulating immune cell recruitment, macrophage polarization, and cytotoxic T cell
responses. In complementary studies using the well-characterized polyomavirus middle T antigen mouse model
of BC, we show that RON loss specifically in mammary epithelial cells phenocopies the reduced growth,
metastasis and changes in the TME as global and tumor cell specific HGFL loss. We also demonstrate a
coordinate upregulation of HGFL and RON in human BCs. To gain mechanistic insights into the RON signaling
pathway, we performed RNA-Seq analyses of RON modulated human and murine BC cells. Surprisingly, we
found RON predominately suppressed pathways involved in Type I interferon (IFN), cytokine and pattern
recognition receptor (PRR) signaling. Investigating these pathways, we discovered a novel connection between
RON and suppression of IRAK4 (interleukin-1 receptor-associated kinase 4), an identified mediator of innate
immune responses downstream of PRRs. We also identified a reduction in IRF7, a key regulator of Type I IFNs,
with RON loss and IRAK4 expression. We show that IRAK4 introduction into RON expressing cells phenocopies
RON loss, while treatment of RON deficient cells with an IRAK4 inhibitor phenocopies RON expression with
respect to tumor growth and Type I IFN production. Based on this data, this proposal will test the hypothesis
that upregulation of tumor cell intrinsic RON promotes BC progression through effects on both the tumor proper
and TME through mechanisms that involve suppression of IRAK4 and ensuing Type I IFN production. Two Aims
are proposed to (i) determine the functional significance of tumor cell intrinsic RON signaling and Type I IFN
disruption in establishing a tumor permissive microenvironment to support BC growth, and (ii) define the role of
RON activation in suppressing the IRAK4-Type I IFN signaling axis to promote BC growth and metastasis. This
work is expected to provide new insights into mechanisms underlying aggressive BCs and will be instructive in
accessing combination therapies to direct clinical studies to combat BC deaths.

Public health relevance
Breast cancer (BC) is a leading cause of cancer related death in American women with higher rates of this disease observed in Veteran populations compared to nonveterans. With the rapid expansion in the number of women Veterans, more women from this group are expected to be diagnosed with BC with heightened needs for women’s health care anticipated. While BC death rates have declined with advances in detection and treatment, a large number of US women are still expected to die of BC. The RON receptor and its ligand, HGFL, are coordinately upregulated in human BCs and recent studies show that RON levels are predictive of metastasis and reduced overall survival. However, the mechanisms by which RON and HGFL contribute to more aggressive BC remain incompletely understood. This study will examine a newly discovered function of these proteins in disrupting innate signaling cascades and will evaluate the efficacy of blocking RON in combination with selective immunomodulatory approaches to combat BC mortality.